PIMAGEDINE IN PATIENTS WITH TYPE II DIABETES MELLITUS AND DIABETIC NEPHROPATHY

Evaluate the safety and efficacy of pimagedine in preserving renal function in patients with type II diabetes mellitus and overt diabetic nephropathy. Parameters assessed include protein crosslinking, all-cause mortality, and cardiovascular mortality and morbidity.